Optimizing Lung Transplant Benefit Using Agent-Based Simulation Modeling Approaches

PROJECT SUMMARY/ABSTRACT
US lung allocation policy has made steady advances in its goal of improving survival of patients with end-stage
lung diseases, but progress is stymied by historically used methodologies that cannot be adapted to capture
the complexity of contemporary lung transplantation. Limitations in the lung allocation policies – including
poorly performing risk models and adverse impacts of strict geographic boundaries – have impeded the ability
to achieve equity in allocation and to maximize utility by optimizing transplant outcomes to promote the
aggregate societal good. This project applies innovative and advanced statistical and mathematical modeling
methodologies toward the goal of achieving equity and maximizing transplant outcomes. Building on the prior
award, we will apply the novel framework for capturing the dynamic state of end-stage lung disease and
advanced simulation techniques, evaluating the effects of alternative allocation strategies on the donor supply,
candidate and recipient outcomes, and system-wide efficiencies. We will seek to understand the impact of the
transition of the US lung allocation system to the Composite Allocation Score (CAS) system, improve the
equity and utility of CAS-based lung allocation, develop a simulation-based lung allocation model and evaluate
the potential impact of using this model to inform allocation decisions. We will introduce and study the potential
improvements in individual- and population-level outcomes that may be achievable by moving from the current
score-based framework focused on individual urgency and benefit to a simulation-based lung allocation
framework focused on the system as a whole.

Public health relevance
PROJECT NARRATIVE The US lung transplant system aims to achieve fairness in access and maximize survival for patients with end- stage lung diseases. In this project, we will study how to improve the US lung transplant system to better achieve these important goals using advanced mathematical models.